ACTG 152--COMPARATIVE TRIAL OF ZDV VS DDI VS ZDV PLUS DDI IN CHILDREN

Multicenter trial of ZDV versus ddI versus combination of ZDV and ddI to evaluate safety, tolerance, and efficacy of treatment arms.